HIV/cervical cancer cOntrol and Prevention clinical sitE in Kenya (HOPE-Kenya)

ABSTRACT
Cervical cancer (CC) is a highly preventable disease and yet hundreds of thousands of women die each year
from CC with the large majority of deaths occurring in low- and middle-income countries (LMICs). LMICs in sub-
Saharan Africa (SSA) are particularly affected because of the dual burden of human papillomavirus (HPV) and
HIV infection which interact with deadly synergism. Women living with HIV (WLWH) have accessed antiretroviral
therapy (ART) across SSA but have yet to fully benefit from integrated CC screening and treatment services.
The challenges lie not in any particular barrier to care but in the many gaps that occur in the cascade of CC
prevention from screening uptake to management of positive cases to treatment access and application. Clinical
research sites are needed worldwide to implement clinical trials that examine potential interventions and one of
the most ideal locations may be found at the Coptic Hope Center for Infectious Diseases in Nairobi, Kenya. Co-
founded by Dr. Michael Chung (MPI) and Dr. Samah Sakr (MPI) at the Coptic Hospital in 2004, the Hope Center
is one of the largest single-site ART treatment centers in Kenya having enrolled over 20,000 people living with
HIV (PLWH) with over 6,000 WLWH currently in care. The Hope Center has been screening WLWH for cervical
cancer since 2005 and has been the site for HIV CC research and many clinical trials conducted by Treatment,
Research, and Expert Education (TREE), which Dr. Chung leads as Executive Director. Based at the Hope
Center, TREE has a powerful physical, administrative, and laboratory infrastructure that has been implementing
HIV clinical trials at the site for over a decade including a study that screened over 6,000 WLWH with
Papanicolaou (Pap) smear and colposcopy-directed biopsy, randomized 400 to cryotherapy and loop
electrosurgical excision procedure (LEEP), and examined recurrence of cervical intraepithelial neoplasia (CIN),
cervical shedding of HIV, and clearance of HPV over 2-year follow-up. In this proposal, Dr. Chung and Dr. Sakr
will co-lead the implementation of a clinical site at the Hope Center in Nairobi by Coptic Hospital and TREE that,
with assistance from Drs. Mary Nderitu (co-I) and Evans Nyongesa-Malav (co-I), will study interventions that
will: 1) increase screening uptake among WLWH; 2) improve management of women who screen positive; and
3) optimize precancer treatment for WLWH. They will achieve this by providing: 1) a pluripotent infrastructure for
accruing participants to network clinical trials from the Hope Center and a network of four Coptic HIV Clinics
throughout the country that are overseen by Dr. Andrew Nagy (co-I) for a total of 6,533 CC screen eligible
WLWH between the ages of 25 and 49; 2) insights and input on clinical significance and study feasibility during
concept and protocol development through the participation of Dr. Chung and Dr. Sakr; and 3) and on-site
operational leadership for the successful conduct of network clinical trials by TREE and its staff led by Dr. Rose
Kosgei (co-I).

Public health relevance
NARRATIVE Because many women living with HIV (WLWH) are also infected with human papillomavirus (HPV), the cause of cervical cancer, they have a very high likelihood of developing cervical cancer over their lifetime. In this project, we propose to implement a clinical site in Nairobi, Kenya at a high-volume HIV treatment clinic called the Coptic Hope Center for Infectious Diseases where clinical trials can be conducted and test interventions to improve cervical cancer screening and treatment for WLWH. At our site, we have the experience and expertise to study methods that can potentially increase the number of women getting screened, improve how women who test positive are managed, and better treat any disease that is detected.